Role and regulation of beta-catenin in cholestatic liver disease

Chronic cholestasis results from bile secretory defects or impairment of bile flow, and there are few effective
medical therapies available. During the past funding period, we have made significant progress in determining
the multifactorial role of the Wnt/β-catenin pathway in cholestatic liver disease (CLD). We show β-catenin
inhibition decreases bile acid (BA) synthesis, limiting CLD and fibrosis after bile duct ligation. However,
inhibition of β-catenin in the Mdr2 knockout (KO) mice, a model mimicking Primary Sclerosing Cholangitis
(PSC), aggravated rather than alleviated injury. In fact, Mdr2-β-catenin-KO (DKO1) mice more closely
resembled PSC cases than Mdr2 KO, suggesting this might be a clinically relevant model to study biology and
therapeutics for PSC. β-catenin is also a critical component of adherens junctions (AJs), where its loss is
compensated by spontaneous increase in β-catenin. We show that deletion of both β- & γ-catenin from
hepatocytes (HCs) & cholangiocytes (CCs) in DKO2 mice resulted in CLD, failure to thrive, increased BA,
fibrosis, and mortality, and resembled progressive familial intrahepatic cholestasis (PFIC), a pediatric CLD.
Although DKO1 and DKO2 had a disparate underlying basis, they share phenotypic commonalities including
loss of hepatocyte differentiation & acquisition of mesenchymal characteristics; loss of cell polarity; and
pertubations in cell-cell junctions. Intriguingly, none of these events have been studied in great depth in CLD
and cholangiopathies, making our study innovative and significant. Based on these findings, we hypothesize
that our DKO models represent a subset of PSC and PFIC cases which will be validated by transcriptomic
analyses. Regardless of the disease subtype, these mice serve as powerful pre-clinical models for in-depth
mechanistic studies of processes such as cell maturation/differentiation, cell polarity and/or cell-cell
junctions, that are less well investigated and understood in disease pathogenesis. We further posit that
modulating the determinants of key processes such as TGFβ signaling & β-catenin in both HCs & CCs, will not
only provide novel insights into the role of β-catenin in cell polarity and cholangiocyte biology, but might also
have major therapeutic implications in the general context of cholangiopathies. We are proposing 3
independent yet cohesive aims to test our hypothesis. In Aim 1, we will validate the relevance of the DKO1 and
DKO2 models to human CLD subclasses. In Aim2, we will investigate the role of TGFβ in progressive CLD
models associated with β-catenin loss, since both our preclinical models are characterized by increased TGFβ
signaling and ensuing loss of cell polarity with enhanced expression of epithelial-to-mesenchymal transition
(EMT) markers. In aim 3, we will determine the role of CC β-catenin in Mdr2 KO mice by its deletion from this
cell type. We will also study the impact of dual deletion of β-γ-catenin in CC. Thus our proposed studies will
comprehensively address the 3 poorly understood processes of epithelial to mesenchymal reprogramming, loss
of cell polarity, and perturbations in cell-cell junctions, in the pathogenesis of CLD.

Public health relevance
PROJECT NARRATIVE Although cholestatic liver diseases are heterogeneous, a subset of patients with cholestasis have decreased expression of β-catenin that may cause or exacerbate disease progression. In this proposal, we will use transcriptomics analysis to validate two mouse models that phenotypically resemble primary sclerosing cholangitis (PSC) and progressive familial intrahepatic cholestasis (PFIC), and determine the subset of PSC and PFIC cases they represent. We will also use these mouse models to assess the contribution of β-catenin to maintenance of cell polarity and cholangiocyte pathobiology in the context of cholestatic liver disease.